Unraveling the Role of Langerhans Cells in Itch

PROJECT SUMMARY
Chronic itch is a considerable medical challenge associated with various skin and systemic diseases, ,
exerting a profound impact on patients' overall quality of life. While the epidermis is conventionally considered
the source of skin itch, critical knowledge gaps persist regarding the role of Langerhans cells (LCs), resident
cells in the epidermis, in mediating itch. LCs play a vital immunologic role in protecting against environmental
antigens and, due to their dendrite-like appearance and proximity to nerve endings, have been associated with
the nervous system. This project aims to comprehensively understand the contribution of LCs to chronic itch,
shedding light on a perplexing condition. LCs can be categorized into resident and monocyte-derived types.
We hypothesize that resident LCs are implicated not only in acute itch but also in chronic itch. Aim 1 will
examine the interaction of LCs with pruriceptors in mouse models of chronic itch. Utilizing transgenic mice
expressing TdTomato in pruriceptors, we will visualize the localization of pruriceptors and LCs in chronic itch
mouse models such as atopic dermatitis, psoriasis, and postburn. Optogenetic stimulation of LCs will be
employed to determine if it activates pruriceptors. Aim 2 will evaluate the contribution of resident and/or
monocyte-derived LCs to itch in mouse models of chronic itch. Utilizing hematopoietic chimeras with Gq-
DREADD and Gi-DREADD expression, we will investigate the roles of resident and monocyte-derived LCs in
spontaneous itch in chronic conditions. Chemogenetic activation and inhibition of these LC subsets will be
explored to understand their influence on chronic itch. Aim 3 will identify and genetically define the
heterogeneous population of resident and monocyte-derived LCs in mouse models of chronic itch. Single-cell
RNA sequencing and cell sorting techniques will be employed to define the heterogeneous population of both
LC types and examine how their dynamics change in mouse models of chronic itch. This comprehensive
investigation seeks to unveil the overlooked role of LC-pruriceptor signaling in promoting spontaneous itch
under diverse chronic conditions. The long-term goal of this study is to identify functional LC subsets,
comprehend their impact on chronic itch, and pave the way for the development of more effective, mechanism-
based treatments for this significant healthcare challenge.

Public health relevance
PROJECT NARRATIVE This research investigates chronic itch, a troublesome medical issue linked to skin and systemic diseases. The study explores the role of Langerhans cells (LCs) in causing itch, specifically in chronic conditions like atopic dermatitis, psoriasis, and postburn. The goal is to understand how LCs interact with nerve endings, evaluate their contributions to chronic itch, and pave the way for better treatments.